Myocyte Mechanics of Right Ventricular Contractile Failure in Pulmonary Hypertension due to Heart Failure with Reduced Ejection Fraction

PROJECT SUMMARY / ABSTRACT
This proposal aims to improve our diagnosis and mechanistic understanding of right ventricular (RV) myocyte
dysfunction in heart failure patients with reduced ejection fraction and pulmonary hypertension (HFrEF-PH).
Our inability to accurately identify RV failure worsens prognostic and therapeutic efforts in many HFrEF-PH
clinical scenarios. RV myocyte contractile reserve indices, such as calcium-activated isometric tension and
length-dependent active tension, are reduced in end-stage human HFrEF-PH RV. The latter, a key contributor
to chamber Frank-Starling reserve, is severely depressed in HFrEF-PH yet entirely uncaptured by clinical
indices. This deficiency highlights one potential reason why clinical tools fall short. A shortcoming of this work
was its study of end-stage disease; correlates of myocyte dysfunction from earlier-stage disease would provide
more clinically useful insight. Our central hypothesis is that clinical identification of RV myocyte disease in
HFrEF-PH requires measuring RV contractile reserve during exercise. Our prior study of primary PH patients
supports this, and new data in patients with PH secondary to heart failure do so as well. We also reveal a novel
mechanism linking poor recruitment of super-relaxed myosin to poor myocyte length-dependent tension. This
links, for the first time in humans, thick filament myosin to RV myocyte and chamber reserve. Dissecting these
findings will clarify mechanism and help guide the use of novel direct-acting sarcomere drugs for such myocyte
deficits. We will test our hypothesis via three Specific Aims. In Aim 1, we test whether RV exercise reserve
measures are better than resting RV measures at identifying RV myocyte contractile dysfunction. We will do
this by prospectively measuring rest and exercise RV function using clinical and pressure-volume loop-derived
RV indices and comparing their ability to identify intrinsic RV myocyte contractile failure, the latter ascertained
from concurrently obtained RV biopsies. In Aim 2, we test whether hypophosphorylation of protein kinase A-
protein targets or hyperphosphorylation of sarcomere Z-disc scaffolding proteins blunts length-dependent
activation in HFrEF-PH RV myocytes. We will assess myocytes under the influence of select kinases and
phosphatases, assess thick filament super-relaxed myosin recruitment, and test the effect of specific
modifications on length-dependent force in human engineered heart tissue. In Aim 3, we test the ability of
novel direct-acting sarcomere drugs, termed myotropes, on ex vivo HFrEF RV myocyte length-dependent
tension. We also test whether newfound Aim 1 clinical measures identify patients with better drug response.
Through this proposal, we expect to deliver novel clinical indicators of intrinsic HFrEF-PH RV myocyte failure.
By coupling these clinical indicators to biophysical mechanisms and drug responses, we hope to usher in novel
treatments for RV failure. These goals, which align with those of the NHLBI, would fulfill a major unmet need
for RV failure due to HFrEF-PH. The PI Dr. Hsu, an early-stage investigator, has developed the necessary
clinical-translational expertise and has assembled an exceptional scientific team to deliver on this proposal.

Public health relevance
PROJECT NARRATIVE Right ventricular (RV) failure is widely recognized to worsen patient outcomes in the setting of heart failure with reduced ejection fraction (HFrEF)-related pulmonary hypertension (PH), yet we fall short in trying to identify and treat it. The current proposal will (1) determine the best clinical indicators of intrinsic RV cardiomyocyte contractile failure in humans with HFrEF-PH, (2) clarify underlying mechanisms, and (3) test novel treatments on RV cardiomyocytes. The long-term goal of this proposal will be to better identify and treat RV failure in humans suffering from HFrEF-PH.